The biogenesis and functions of pre-meiotic small RNAs in male reproductive development in maize

PROJECT SUMMARY
In numerous flowering plant species, the male reproductive organs (anthers), which nurture pollen grains
(containing the sperm, the male germline of plants) and their progenitor cells, accumulate two classes of small
RNAs, i.e., the pre-meiotic (21-nt) and meiotic (24-nt) phased, small interfering RNAs (phasiRNAs).
Perturbation of the phasiRNA biogenesis pathways in rice or maize causes environmentally-sensitive male
sterility. There are many interesting parallels between these plant phasiRNAs and animal PIWI-interacting
RNAs (piRNAs), which have also been shown essential for male fertility. However, there is a major gap in our
understanding of how the plant reproductive phasiRNAs function to regulate developmental processes
important for reproduction. Our long-term goal is to understand mechanistic and functional basis for the
dependence on these small RNAs in plant male reproductive development.
We and collaborators have described the reproductive phasiRNA pathways in many plant species. We
have shown that biogenesis of the 21-nt, pre-meiotic phasiRNAs is initiated in the anther epidermis, but they
accumulate in the tapetum, three layers of cells distal, indicating movement across cell layers. Yet, it is largely
unknown where the 21-nt phasiRNAs and their biogenesis components localize throughout anther
development, as well as what are the targets and thus precise functions of the 21-nt phasiRNAs. Our strong
preliminary data has led to our focus on three Specific Aims to characterize 21-nt, pre-meiotic reproductive
phasiRNAs in maize, a model for plant reproductive biology, genomics, and genetics. The aims are: (1)
Characterize the spatiotemporal localization of key players in pre-meiotic phasiRNA biogenesis, using
advanced imaging and single-cell RNA-seq techniques; this aim will generate a spatiotemporal map of 21-nt
phasiRNAs, their precursors, microRNA trigger, and biogenesis proteins, in developing maize anthers. (2)
Decipher the biogenesis of pre-meiotic phasiRNAs and their developmental roles, via the identification of novel
biogenesis factors using biochemical approaches, using publicly available mutants plus CRISPR-Cas9-
generated mutants to understand whether the pre-meiotic phasiRNAs are necessary for male reproductive
development, and then assign functions to novel components of the pathway. And (3) elucidate the regulatory
mechanisms mediated by pre-meiotic phasiRNAs, using established and new molecular approaches to identify
the endogenous targets of 21-nt phasiRNAs and examine how they are regulated by the phasiRNAs.
The proposed research will have a broad impact on small RNA biology by characterizing the biogenesis
and functions of pre-meiotic plant small RNAs in maize anther development. The experiments will provide key
insights into where and how they are produced, and what their roles are in anther cell differentiation and male
fertility. Comparison of the results of this work with ongoing studies into mammalian piRNAs may shed light on
the commonalities in the utilization of small RNA pathways in reproduction and gonad development.

Public health relevance
PROJECT NARRATIVE Plants express small RNAs that accumulate to high levels in reproductive organs harboring the male germline; these small RNAs show interesting parallels to the animal piRNAs, and perturbation of their biogenesis or activities causes sterility. Our proposed study aims to understand the localization, biogenesis, functions, and targets of a specialized class of the small RNAs (the 21-nt phased, small interfering RNAs) that are abundant prior to meiosis, using the maize as the model system. The research outcomes will provide mechanistic insights into the biogenesis and functions of these small RNAs, with the potential to illuminate why plants have evolved this unusual small RNA pathway enriched in or even specific to male reproduction.